Effects of Vascular Runx 2 deletion on osteogenesis and calcification in vessels

DESCRIPTION (provided by applicant): Uremic vascular calcification (UVC) is not simply a result of elevated phosphorus and calcium levels. Disregulation in inhibitory and promoting factors, greatly contribute to mineralization in vessels. Osteogenic differentiation in VSMC has emerged as a potential pathogenetic mechanism for UVC during last decade. Runx2 is the master gene for osteogenic program and without it VSMC cannot undergo osteochondrogenesis. Based on our preliminary results, we hypothesize, that, osteogenic differentiation may promote, but is not an absolute requirement for vascular calcification. Unfortunately, to test this hypothesis, embryonic Runx2 KO, or isoform selective Runx2-I or Runx2-II KO mice cannot be used. These mice do not survive long enough to be used in prolonged uremic experiments. We propose to use aorta transplantation from mice with Runx 2 gene isoform specific, as well as total Runx2 inactivation into WT mice to create VSMC specific Runx2 KO chimeras and test the effect of complete inhibition of VSMC osteogenic differentiation on vascular calcification in uremia. We also propose to examine if Runx2 overexpression is capable of launching osteogenic program in vessels in otherwise normal mice, mice fed high phosphorus diet and in uremic mice. Inducible global Runx 2 overexpression mouse model exists, but mice only survive 2 weeks, not long enough to develop vascular calcification. We will use the aorta transplantation technique to create chimeras with VSMC-specific Runx2 overexpression to test its effects on vascular osteogenesis and calcification.

Public health relevance
Runx2 mediated osteogenic differentiation in VSMC may have pathogenic role in vascular calcification in uremia. We hypothesize, that vascular calcification may occur without osteogenic differentiation. Runx 2 deficiency aborts osteogenic program in all cells including bones. We propose to use Runx 2 deficient and overexpression mice models in uremic vascular calcification experiments, in order to elucidate role of osteogenesis in vascular calcification.